Targeting apoptotic cells to enhance radiotherapy

ABSTRACT
Radiation therapy is a potent element of standard cancer care, used in the treatment of over half of all
cancer patients. While the clinical benefits of radiotherapy are well documented, the dose to adjacent and
intermeshed normal organs and subsequent toxicity remains the biggest obstacle to continued escalation of
radiation doses to tumors in order to obtain cancer cures with RT. Significant number of patients will develop
locally persistent/recurrent tumors after radiotherapy. Therefore, radiosensitizing compounds, radiosensitizers,
have been developed to enhance tumor killing effects without escalation of radiation doses. However, their
clinical applications are limited due to invasive or insufficient tumor delivery and lack of specificity or systemic
toxicity. The goal of this project is to develop a prodrug-based therapeutic strategy empowered by a
nanotechnology pioneered by us —in cellulo nanoassembly—to amplify and enhance radiotherapeutic efficacy
for treating prostate cancer. Unlike common nanoparticle-based delivery approach, this delivery strategy does
not rely on the tumor enhanced permeability and retention effect. We propose to take advantage of the intrinsic
heterogeneous response to radiation therapy by targeting this initial population of apoptotic cells for depositing
radiosensitizers and enhancing radiotherapeutic effects. The project will develop and characterize the new
prodrug radiosensitizers for targeting apoptosis (Aim 1); investigate the pharmacokinetics, toxicity and validate
the in vivo treatment mechanism (Aim 2); and develop an image-guided treatment strategy, followed by a
comprehensive evaluation of the therapeutic benefit in orthotopic prostate cancer mouse models (Aim 3).

Public health relevance
Project Relevance The proposed research aims to develop a novel general strategy to enhance radiotherapy for cancer treatment. These results will help advance cancer therapy with better treatment outcome and quality of life while the radio- and chemo-toxicity to healthy tissues is much minimized.